A nucleus-to-mitochondria nucleic acid-sensing pathway prevents bypass of age-associated proliferative boundaries

Project Summary
A nucleus-to-mitochondria nucleic acid-sensing pathway prevents bypass of age-associated
proliferative boundaries
Development of immortality as function of age is dependent on the ability of cells to escape from at least two
distinct proliferative barriers, replicative senescence and crisis. Both serve as critical tumor-suppressors, but the
pathways governing them are distinct. Replicative senescence is triggered by short functional telomeres,
dependent on the p53/pRB tumor suppressor pathways and characterized by permanent cell cycle arrest and
continued metabolism. When p53/pRB pathways are dysfunctional, senescence entry is compromised, and cells
continue to proliferate until their telomeres become dysfunctional and chromosome fusions arise. This triggers
replicative crisis, a p53/pRB-independent state, where the vast majority of cells rapidly succumb to cell death.
However, rare cells can even overcome this barrier and become neoplastic, pointing to replicative crisis as one
of the final barriers against age-associated tumor cell initiation. Recently, it was discovered that cell death in
crisis is governed by macroautophagy through a pathway in which cytoplasmic DNA species from fused and
broken chromosomes activate the cGAS-STING cytoplasmic DNA-sensing response that normally detects viral
DNA. Suppression of autophagy allowed cells to bypass crisis and continue to proliferate, while accumulating
genome instability. This discovery represented the first crisis-bypass system, which allowed the design of a
CRISPR suppression screen aimed at identifying factors required to protect cells against age-associated cancer
initiation. Another nucleic acid sensor, ZBP1 emerged as critical for the crisis program, which was confirmed by
ZBP1 suppression allowing cells to proliferate beyond crisis. Here, in three synergistic aims it is proposed to
decipher the mechanism underlying the ZBP1-dependent inhibition of cancer initiation. AIM1 will determine the
interactions between dysfunctional telomeres, telomeric (TERRA) transcripts and ZBP1 and define the
mechanisms of ZBP1-mediated innate immune signaling on mitochondria during crisis. AIM2 is designed to
investigate the mechanism of the mitochondrial localization of the crisis-specific isoform of ZBP1 and its relevant
interacting partners. Finally, the ability to allow cells to proliferate beyond crisis revealed the existence of a third
previously unknown proliferative barrier against cancer initiation (called M3), which will be extensively
characterized in AIM 3. Successful completion of these aims will shed new light on crosstalk between telomeres,
mitochondria and inflammation (three established hallmarks of aging), the role of a telomere-to-mitochondria
innate immune signaling pathway in the prevention of age-associated cancer and establish biomarkers and new
approaches to understand the relevance of the new M3 proliferative barrier as tumor-suppressor.

Public health relevance
Project Narrative Age associated neoplastic transformation is the result of individual cells escaping tumor suppressive barriers during the lifetime of an organism. Successful efforts towards preventing cancer initiation during aging are dependent on understanding and enhancing the proliferative barriers that govern tumor suppressive barriers. This proposal focuses on the mechanisms that are in place to eliminate precancerous cells during replicative aging, suggesting that crosstalk between telomeres, mitochondria and the inflammation machinery is critical to protect an aging organism from cancer development.